Synaptic plasticity underlying sex differences in aggression reward

Project Abstract
The ability to efficiently defend one’s home territory from intruders is an essential behavioral adaptation.
However, the neurobiology of this experience-dependent plasticity is unknown. Furthermore, the neural
mechanisms in females and sex differences are also unknown; these are critical barriers of therapeutic
interventions aimed at improving mental health. My graduate research suggests that females are more
sensitive to the rewarding effects of aggressive experience and that oxytocin (OT) transmission may underlie
these sex differences. My recent post-doctoral studies support synaptic plasticity in the prefrontal cortex (PFC)
and nucleus accumbens (NAc) underlies the adaptive consequences of aggressive experience. Thus, the goal
of this proposal is to synthesize my research by 1) acquiring training in state-of-the-art electrophysiological
techniques and investigate aggression-induced synaptic plasticity of PFC input to medium spiny neurons
(MSNs) in the NAc, and 2) then apply these new skills to assess the contribution of OT to synaptic plasticity of
NAc MSNs. Both phases will advance our understanding of the causal role of two distinct circuits in driving
aggression reward in both sexes, and provide the training and resources to establish my independent career.
Under the collective mentorship of Drs. Patrick Rothwell (primary mentor), Robert Meisel (co-mentor),
state-of-the-art research facilities, and expert research consultants, I will have access to a unique and custom
set of resources. Dr. Rothwell will lead my training in slice electrophysiology, optogenetics and calcium
imaging with fiber photometry. To elucidate specific components of neuronal physiology, I will learn how to
measure the effects of aggressive experience on basal synaptic strength of NAc MSNs in male and female
Syrian hamsters. I will then assess the effects of aggressive experience on calcium signaling of NAc MSNs in
male and females. In combination, I will also utilize optogenetics to assess the involvement of PFC glutamate
projections in driving physiological changes and aggression reward in males and females. I predict enhanced
PFC synaptic transmission onto NAc MSN drives aggressive experience-dependent behavioral plasticity, e.g.
aggression reward and motivation.
For the R00 phase I will establish an independent research lab and then implement the skills acquired
during the K99 to investigate the role of OT in NAc synaptic plasticity, as well as driving aggression reward and
motivation in males and females. OT has been historically considered a monotonic love hormone. However,
this proposal seeks to further revolutionize our understanding of the non-canonical and non-monotonic nature
of OT and improve sex-specific therapeutic strategies to combat psychiatric disease. I predict OT is a mediator
of the NAc MSN synaptic plasticity that drives the enhanced aggression reward and motivation in females
compared to males. Collectively, this proposal will provide me skills and professional development for running
a research lab that makes fundamental discoveries about brain function to combat mental illnesses.

Public health relevance
Project Narrative Aggression is often considered a “negative” behavior, but proper display of aggression is essential for self- preservation and maintenance of resources. The negative context of aggression has limited its study as a motivated behavior, yet it is critical to understand the adaptive as well as the maladaptive consequences of aggression in both sexes, in order to appreciate the underlying neurobiology and improve mental health outcomes. This proposal will advance our understanding of synaptic plasticity driving aggression reward and motivation, including the roles of glutamate and oxytocin.